Functional Genetics Approaches to Investigate Human Evolution

Analyses of human and chimpanzee genomes have catalogued the single-nucleotide and structural variants that
have emerged since humans diverged from nonhuman primates. Nearly all of these genetic variants remain
functionally uncharacterized. Contained within these genetic variants are alterations to cis-regulatory elements,
protein-coding genes, noncoding RNAs, gene copy number, repetitive elements, and other genomic features
that underlie phenotypic differences between humans and nonhuman primates. Because it is difficult to predict
how genomic differences within the hominid lineage contribute to phenotypic differences, there is a critical need
for high-throughput, systematic approaches to interrogate functional genetic variation. Therefore, I seek to
develop a quantitative genome-scale platform for identifying the phenotypic consequences of human-specific
evolutionary mutations at a cellular and molecular level. To accomplish this objective, I will combine advances
in chimpanzee pluripotent stem cell-derived models with CRISPR interference (CRISPRi), single-cell RNAsequencing (scRNA-seq), and single-cell ATAC-sequencing (scATAC-seq). This project is of great

Public health relevance
public health relevance because it will use genetic and molecular techniques to link evolved human-specific genetic variants to key cellular processes such as survival, proliferation, differentiation, gene expression, and chromatin state regulation. In Aim 1, I will functionally investigate thousands of human-specific deletions (hDels), structural variants that are lost in the human lineage, using a genome-scale CRISPRi screening approach in chimpanzee induced pluripotent stem cells (iPSCs) and neural progenitor cells (NPCs). I hypothesize that hDels contain celltype specific cis-regulatory elements that modify robust cellular proliferation. In Aim 2, I will map cis-regulatory elements contained within hDels to their target genes using scATAC-seq of embryonic rhesus macaque telencephalon followed by CRISPRi and scRNA-seq in chimpanzee NPCs. I hypothesize that hDel-containing cis-regulatory elements control genes involved in cellular division, apoptosis, and migration. In addition to Dr. Pollen’s expertise in comparative genomics and single-cell transcriptomics and Dr. Katherine Pollard’s expertise in theoretical population genetics and machine learning, our ongoing local collaborations with Dr. Martin Kampmann (CRISPR-Cas systems), Dr. Hani Goodarzi (computational and statistical methods), and Dr. Nadav Ahituv (cis-regulatory evolution), support the feasibility of this project. Evaluating the cellular and transcriptional consequences of perturbing human-specific genetic variants will reveal functional sequences that may have contributed to human evolution.